Entamoeba histolytica as the new model system for studying excystation

PROJECT SUMMARY
The complex life cycle processes of encystation and excystation in Entamoeba represent potential targets
for therapeutic intervention but have not been studied directly in the human pathogen Entamoeba histolytica
because of an inability to produce cysts in a laboratory setting. Instead, scientists have been forced to rely on
studies with the distantly related reptile pathogen Entamoeba invadens. Our lab has established a method for
reproducible encystation of E. histolytica in laboratory culture and in this project we propose to develop
reproducible, high efficiency excystation as well. E. histolytica causes amoebic dysentery in ~100 million
people each year worldwide, although as many as 1 billion people may be infected each year as only ~10% of
infections result in symptomatic disease. The inability to study encystation and excystation in the laboratory
has greatly hindered investigation of the life cycle and infection process. The long-term goal of our research
program is to determine how E. histolytica senses and adapts to different environments it encounters during
infection. Encystation and excystation are the two key adaptations, allowing Entamoeba to continue the
disease process through dissemination of infectious cysts. Having established a reproducible system for
encystation of E. histolytica in culture, we are now able to do the same for excystation, thus allowing us to
study these critical processes in the lab to pursue an understanding of how E. histolytica senses and responds
to environmental cues that signal conversion from motile trophozoite to infectious cyst and back. As part of our
long-term goal, the overall objective of this proposal is to develop a reproducible method for high efficiency
excystation of E. histolytica in vitro cysts. To this end, we will use two approaches: (1) increase excystation
efficiency with standard in vitro cysts; and (2) produce in vitro cysts that exhibit high efficiency excystation. We
will apply these two approaches iteratively, such that we will identify the optimal combination of conditions for
both encystation and excystation that leads to reproducible, high efficiency excystation. This research will have
a significant impact by laying an important foundation for future studies on excystation of the human pathogen
such that we can identify and characterize the roles of key genes required for this essential disease process.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it investigates an essential stage of the infection process of Entamoeba histolytica, a major public health problem in many developing countries. We established a method for producing infectious cysts in vitro and will now develop a procedure for reproducible, high efficiency excystation of cysts in laboratory culture, thus allowing us to study this key process. This will provide a critical foundation for future studies to develop mechanisms targeting this stage of infection as a way to reduce the spread of this disease pursuant to part of the NIH’s mission.